CMA: Cancer Stem Cells in the Pathogenesis and Treatment of Colorectal Cancer

ABSTRACT
This proposal is being submitted as part of a group of linked merit review applications from nationwide VA
experts in colorectal cancer (CRC) who have formed a colorectal cancer cell-genomics consortium (VA4C)
after participating in a successful field-based meeting in Chicago in May 2017 (funded by VA ORD).
Specifically, this proposal will be part of a cluster of merit review projects that are aimed at advancing our
understanding of CRC pathogenesis and treatment response with a focus on the roles of the microbiome and
CRC stem cells. The importance of the intestinal microbiome to the development and progression of CRC is
supported by a range of evidence including epidemiological links between diet and CRC risk, reproducible
associations of specific microbes such as Fusobacterium with human CRC, mouse models indicating
augmentation of CRC formation and metastasis by microbiota, and mouse models showing that the
microbiome modulates chemotherapy response. We hypothesize that: 1) The intestinal microbiome, through
direct invasion of tumor tissue and release of bioactive microbial products, is associated with specific CRC
clinical/histologic phenotypes and molecular subclasses defined by transcriptional profiles. 2) The intestinal
microbiome influences the risk of recurrence after surgery and chemotherapy by modulating anti-tumor
immunity and the metabolism of chemotherapeutics. 3) The treatment of locally advanced CRC with surgical
resection and chemotherapy alters the intestinal microbiome, which may influence the likelihood of future
recurrences. To study these hypotheses, in Aim 1 we will utilize the multi-center clinical infrastructure of this
CMA to collect fecal and tumor samples from 400 male and female Veterans with stage I-III CRC for analysis
of the microbiome, metabolome, and transcriptome. Intestinal microbes and metabolites will be identified that
are associated with tumor phenotype and molecular signature, as defined by gene transcripts, functional
pathways and non-coding RNAs. In Aim 2, we will perform longitudinal follow-up of 200 Veterans with stage II-
III colorectal cancer to elucidate baseline microbes and metabolites that predict subsequent risk for recurrence.
In addition, we will obtain fecal samples before, during and after surgery then chemotherapy, and annually
thereafter to identify microbial shifts with treatment and their association with future recurrence. In Aim 3, we
will link compositional and functional shifts in the intestinal microbiome to CRC by using the C57BL/6 ApcMin
strain of mice that is highly susceptible to spontaneous intestinal adenoma formation. We will examine the
effect of colonization with human microbiota obtained from patients with high or low immune infiltration and
immune transcriptional state, to assess adenoma/CRC formation and the intratumor immune response. We will
also study the response to chemotherapy in mice engrafted with CRC cells and colonized with the stool of
patients that had a recurrence, or a sustained remission, to evaluate microbiome-mediated differences in
therapeutic response.

Public health relevance
Colorectal polyps and colorectal cancer are prevalent conditions in the US population and in our Veterans. Over half of the Veterans seen in VA clinics are affected and colorectal cancer is the second leading cause of cancer deaths among Veterans. Multiple co-morbidities and prior exposure to toxins and radiation contribute to the Veterans’ higher incidence of primary CRC (8.6% compared to 4.3% than the rest of the population) in the US. The proposed project aims at identifying novel microbiome, metabolome and transcriptome associations with colorectal tumor phenotypes and clinical outcomes in Veterans, thereby expanding our understanding the microbiome/metabolome effects on CRC phenotypic expression and response to therapy. These studies hold the promise to transform clinical practice related to CRC risk assessment, screening and prevention, thus allowing VA providers to deliver personalized, proactive and patient-driven health care as envisioned by the VA’s Blueprint for Excellence.